Study of the Development and Function of the Uterine Lymphatics

Abstract
The lymphatic system is the central regulator of fluid homeostasis in the body through absorbing and returning
interstitial fluid back to blood circulation; additionally, it plays pivotal roles in lipid digestion and immune and
inflammatory response through the lymphoid organs and immune cell trafficking. Studies have documented the
presence of lymphatics in the uterus; however, little consensus exists regarding the exact development and
distribution of the uterine lymphatics nor their impact on uterine health functions. Understanding the proper
development and maintenance of the lymphatics may be of clinical importance, as lymphatics have been
implicated in pathogenesis uterine diseases such as endometriosis and cancer metastasis. In this study, we
propose to elucidate the development and functions of uterine lymphatics using Prox1 fluorescent lymphatic
reporter and lymphatic loss of function mouse models. Based on preliminary data, we hypothesize that the
uterine lymphatics develop postnatally under patterning guidance from uterine blood vessels, and that uterine
lymphatics remodel to maintain fluid homeostasis of the uterine environment through estrous phases and
pregnancy. After characterizing normal development of the murine uterine lymphatics, we will determine the
function of uterine lymphatics in the context of fluid drainage of the uterine tissue and regulation of embryonic
implantation sites and gestation. The maintenance of fluid homeostasis in the uterus through estrous phases
and pregnancy will be assessed through real-time tracer studies and wet/dry tissue weight ratios, while the role
of uterine lymphatics in embryonic implantation will be dissected through use of novel genetic and surgical
inducible lymphatic loss of function mouse models. Together, these study outcomes will generate a novel
understanding of murine uterine lymphatic morphology and function, which may provide a valuable new
viewpoint from which to assess uterine health.

Public health relevance
Project Narrative The proposed research project aims to characterize the development and functions of the murine uterine lymphatics: we hypothesize that the uterine lymphatics develop postnatally under molecular patterning guidance from uterine blood vessels and functionally, they maintain fluid homeostasis within the uterine environment throughout estrous phases and pregnancy and are essential for successful embryonic implantation and gestation. This study has the potential to not only address the dearth of academic knowledge on uterine lymphatics but also provide novel understanding of the basis of uterine fertility and disease from the lymphatic perspective.